Centralized Research Core Facility

RI-INBRE Centralized Research Core Facility (CRCF) Project Summary
The overarching goal of the Rhode Island IDeA-Network of Biomedical Research Excellence (RI-INBRE)
program is to improve institutional capacity for biomedical research excellence and student experiential training
in the State of Rhode Island. The RI-INBRE Centralized Research Core Facility (CRCF) provides investigators
at both RI-INBRE network institutions and users throughout the state with access to over 40 state-of-the-art
instruments at the lead institution, the University of Rhode Island, and selected satellite locations at partner
institutions. This is a critical resource, especially for early-career investigators, as many of these instruments are
cost-prohibitive for individual labs. The CRCF provides operational training for investigators and their students
on a wide range of analytical and biophysical equipment. In the renewal period, the CRCF will actively market
its services and ensure that equipment and expertise are readily accessible to both RI-INBRE network
investigators and external users. To increase efficiency and improve user experience, the CRCF will collaborate
with the Data Science – Molecular Informatics Core to streamline and unify the omics data generation and
analysis pipelines. The CRCF will also support student and incumbent worker training via an innovative
certificate-granting Workforce Development and Training program which will foster the development of a highly
skilled scientific workforce. By implementing these aims, the CRCF will continue to provide efficient, high-quality
research instrument support that keeps pace with the growing data science landscape. Creating a robust
workforce training program in the CRCF will significantly improve undergraduate student preparation for highly
skilled biotechnology jobs. Marketing services to new academic and industry partners will increase the CRCF
user base, which will meet biomedical research instrumentation needs and support the growth of biotechnology
start-ups in RI.